Center for Advanced Metabolic Imaging in Precision Medicine (CAMIPM)

ABSTRACT
The “Center for Advanced Metabolic Imaging in Precision Medicine (CAMIPM)” is a National Center for
Biomedical Imaging and Bioengineering (NCBIB) that will develop and translate cutting edge noninvasive
metabolic imaging biomarkers for use in biomedical research. Technology development is focused in four major
application areas: Oncology, Cardiovascular, Neuropsychiatric, and Musculoskeletal. Driven by collaborators
across the country and in partnership with Penn’s clinical research institutes in these areas, a range of novel
technologies will be developed, optimized, and implemented with the goal of providing mechanistic
understanding of disease states based on fundamental biological properties that can also serve as treatment
targets and biomarkers for monitoring therapeutic interventions. The proposed technological development will
span from bench to bedside and will include a significant clinical research component.
Four synergistic technological research and development (TR&D) projects will focus on 1) Chemical Exchange
Weighted Molecular MRI for metabolic mapping in brain, heart, skeletal muscle, and tumors, 2) MRI Mapping of
Oxygen Consumption in brain, muscle, and placenta 3) Down Field Spectroscopy of brain, heart, skeletal muscle,
and tumors, and 4) Diffuse Optical imaging in tumors, brain, and muscle. Each of these TR&D projects will
innovate and validate novel strategies for measuring tissue metabolism and translate these technologies to
clinical populations through its collaborative projects, and dissemination through sharing of instrument design,
MRI pulse sequences, data processing pipelines, and sample data as well as serving a multitude of funded
service projects. The CAMIPM also proposes an extensive training and dissemination program in biomedical
imaging through seminars, workshops, peer reviewed publications, targeted courses, hands-on training and a
dedicated website and will train collaborators, service project investigators, students, postdoctoral fellows, and
visiting scholars in the resource developed technologies. Core investigators have an outstanding track record of
imaging technology research, technology dissemination, and of training the next generation of scientists in
biomedical imaging technologies. An administrative component consisting of both internal and external advisory
committees will oversee the fiscal matters, day-to-day activities as well as coordinate the TR&Ds, collaborations
and service components. This project leverages an outstanding biomedical research environment with extensive
resources for biomedical imaging research, strong institutional support, a compact campus housing nationally
leading research and health care enterprises in very close proximity to basic science and engineering
departments, closely integrated clinical-research institutes, and outstanding faculty and trainees. With its stellar
faculty and unique biomedical focus, the CAMIPM is committed to interdisciplinary pursuit of basic and clinical
research through technology development driven by its collaborators and through service to users geographically
distributed across the country and thus has all the attributes required for a national NCBIB.

Public health relevance
Narrative: This NCBIB will develop, translate, and disseminate novel noninvasive metabolic imaging technologies to enhance biomedical research, diagnosis, and management in the areas of oncology, cardiovascular disease, neuropsychiatry, and musculoskeletal disorders. These technologies will have substantial impact on the fundamental understanding of disease mechanisms, early diagnosis, and development of novel therapies for several diseases such as Alzheimer’s disease, Epilepsy, Arthritis, Cancer, Stroke, and heart disease, and thus contribute to precision medicine and enhanced patient care.